Behavioral and Neural Heterogeneity in OCD and Depression

Project Summary
This project investigates behavioral and neural heterogeneity in obsessive-compulsive disorder (OCD) and major
depressive disorder (MDD) using hypothesis- and data-driven approaches. OCD and MDD are major sources of
disability worldwide, with fewer than half of patients responding adequately to first-line treatments. Treatment
may be impeded by the fact that OCD and MDD are both highly heterogeneous, with clusters of symptoms likely
derived from differing psychological and neurobiological etiologies. The Research Domain Criteria (RDoC)
framework seeks to address this problem in part by investigating dimensional components of behavior that span
across disorders and more closely align with brain circuitry than does the multifaceted diagnostic phenotype. In
the present project, we follow an RDoC approach to the study of heterogeneity by investigating relationships
between behavior, clinical symptoms, and brain function using task-based and resting-state fMRI in a sample of
75 OCD patients and 75 MDD patients. Our preliminary data in OCD patients and individuals with depressive
symptoms point to interoceptive sensitivity (IS) and perseverative negative thinking (PT) as dimensional
components of behavior that are not only transdiagnostic but also explain important within-disorder
heterogeneity; the first aim of this proposal builds on these findings by investigating associations of IS and PT
with clinical symptoms, behavior, and brain function in OCD and MDD. Complementing this hypothesis-driven
approach, the second aim of the project is a data-driven investigation using unsupervised machine learning (ML)
to uncover neurobiological profiles that characterize variability in brain function across OCD and MDD. Building
on our preliminary analysis identifying three subgroups within OCD distinguished by differential patterns of
resting-state functional connectivity, we will investigate neurobiological heterogeneity across OCD and MDD and
link clinical and behavioral data to neurobiological subgroups using a comprehensive ‘deep phenotyping’
approach to data acquisition and analysis. The overarching goals of both aims are to identify factors contributing
to heterogeneity that can be developed as novel targets for personalized treatments based on an individual
patient’s neurobehavioral profile.

Public health relevance
Project Narrative Obsessive-compulsive disorder (OCD) and major depressive disorder (MDD) are common and disabling psychiatric disorders, treatments for which have been hindered by their heterogeneity in clinical presentation and underlying mechanisms. This project investigates the heterogeneity of clinical symptoms, behavior, and brain function in OCD and MDD using hypothesis- and data-driven approaches. The overall goals of this work are to identify factors contributing to heterogeneity that can be developed as novel targets for personalized treatments.